ADDITION OF FIBER TO AN ENTERAL FORMULA ON ENERGY AND MICRONUTRIENT BALANCE

Fiber can affect nutrient balance and micronutrient absorption and losses. The objective of this study is to compare energy and micronutrient balance between two enteral formulas - one containing fiber and the other one with no fiber - in children dependent on tube feedings.